Citizen-Science Technology for Healthy Living at Home

Abstract
Human exposure to air pollution is the leading environmental risk factor for premature morbidity and mortality
worldwide and, in the United States (U.S.), people of color suffer from many diseases associated with exposure
to air pollution at higher rates than white people. Our understanding of human exposure to air pollution is based
largely on measurements of outdoor pollutant concentrations and a multitude of studies have found that,
following decades of discriminatory housing and land-use policies, people of color are more likely to live in U.S.
neighborhoods with higher concentrations of outdoor air pollution; however, outdoor air pollution data do not
capture the full picture of human exposure. People living in the U.S. spend most of their time indoors at home
and prior studies have found that in-home air pollutant concentrations—which, being a combination of pollution
from outdoor and indoor sources, are also likely to be impacted by the aforementioned discriminatory policies—
tend to be better-correlated with personal exposures than outdoor concentrations. In-home air pollution is rarely
characterized due to the cost and complexity of setting up large, noisy, finicky monitors in private residences.
The goal of this Phase II SBIR project is to reduce the amount of air pollution U.S. residents are exposed to at
home by making characterization of in-home air quality easy; affordable; useful to home occupants; and
widespread enough to influence local-, state-, and national-level policies.
The first aim of this project is to develop a small, quiet, easy-to-use “Home Health Box” (HHB) that measures
indoor concentrations of particulate matter, volatile organic compounds, carbon dioxide, and nitrogen dioxide
using a combination of low-cost sensors and high-fidelity integrated samplers. The HHB is designed to eliminate
the need for an air quality professional to go to the home; once the HHB is delivered, an occupant simply needs
to set it in a central location, plug it in, and switch it on. Data collected by the HHB will undergo automated
analyses, be reviewed by an air quality professional, and then be synthesized into a report that will (a) compare
measured pollutant levels to guidelines, (b) describe potential pollution sources, and (c) suggest affordable
actions that occupants could take to improve their in-home air quality.
The second aim of this project is to evaluate whether HHB sampling and subsequent receipt of a personalized
“Home Health Report” (HHR) helps households improve their in-home air quality over time. A racially- and
ethnically-diverse group of households will be recruited in partnership with healthcare providers and community
organizations in Denver and Chicago. Homes will be randomized into intervention and control groups. Homes in
both groups will receive three, one-week HHB deployments spaced six weeks apart. After each of the first two
deployments, homes in the intervention group will receive a HHR. We will (a) investigate whether and how air
quality changes over time in control and intervention homes and (b) survey intervention households on the utility
of the Home Health Reports. All homes will receive a HHR at the end of the study.

Public health relevance
Project Narrative Exposure to air pollution is the leading environmental risk factor for the global burden of disease. People living in the United States (U.S.) spend most of their time indoors at home, and data from several U.S.-based studies suggest that the majority of personal exposure to air pollution occurs at home, but the paucity of in-home air pollution monitoring makes it difficult to characterize or reduce at-home exposures. We will develop technology that makes it more convenient and affordable to measure air pollutant levels inside a home, thus making it possible to characterize air quality inside a large number of homes and providing households, community organizations, and government entities with information that can help them take action to reduce the amount of air pollution to which they, their members, and their constituents, respectively, are exposed.